Harnessing single cell epigenome-wide profiling of myeloid cells to compare and contrast Alzheimer's from HIV-associated cognitive dysfunction

PROJECT SUMMARY/ ABSTRACT (for Alina Pang (Ndhlovu): R01 AG063846-01A1
Supplement Application)
In this application, we seek a diversity research supplement to parent award “HARNESSING SINGLE CELL
EPIGENOME-WIDE PROFILING OF MYELOID CELLS TO COMPARE AND CONTRAST ALZHEIMER'S
FROM HIV-ASSOCIATED COGNITIVE DYSFUNCTION” (AG063846-01A1). The parent award seeks to
define the epigenomic landscape of myeloid populations in order to differentiate HIV Associated
Neurocogntivie Disease (HAND) from Mild Cognitive Impairment state of Alzheimer’s Disease (MCI-AD) in
individuals living with HIV on suppressive antiretroviral therapy (ART). This diversity supplement will expand
the scope of research in Specific Aim 1 to include epigenetic signatures of cell free DNA (cfDNA) to further aid
in elucidating the pathogenesis of neurocognitive impairment observed in people living with HIV (PLWH) and
provide postdoctoral training in epigenetics and immunology in the pathogenesis of HAND. The goal of the
diversity supplement is for Dr. Pang to gain experience and preliminary data on epigenetic signatures in the
periphery specific to neurocognitive impairment to submit a K01 application in 2023.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE: This study proposes to use comprehensive profiling of the patients' own immune cells circulating DNA in blood to guide how to diagnose and treat brain impairments seen between older HIV individuals from those afflicted with early stages of Alzheimer's disease.